Multimodal Approach for Diagnosis and Prognosis of Metabolic and Alcohol-Associated Steatotic Liver Diseases

PROJECT SUMMARY
Alcohol-associated liver disease (ALD) and metabolic dysfunction-associated steatotic liver disease (MASLD)
are leading causes of liver transplantation, morbidity, and mortality. With the obesity epidemic and increasing
alcohol consumption, a mixed-etiology disease, metabolic syndrome-associated alcoholic liver disease
(MetALD), has emerged. Accurate diagnosis and risk prediction of ALD, MASLD, and MetALD are currently
hindered by the lack of distinct histological features. To address this critical knowledge gap and its impact on
diagnostic accuracy and the development of precision medicine, this proposal introduces an innovative
approach that harnesses the power of multi-omics data integration using machine learning (ML) techniques.
Our central hypothesis is that each disease has distinctive features identifiable by ML and spatial
transcriptomics, enabling the development of new diagnostic and prognostic tools. The rationale for this is that
current histological methods lack specific features, whereas ML has shown potential for enhanced diagnostic
accuracy. In our preliminary data: 1) we developed several ML tools, including one that distinguishes between
ALD and MASLD with high accuracy, another that assigns zones in liver biopsy whole slide images (WSI), and
identified a morphometric signature for severity in ALD; 2) we identified a unique zonal gene signature profile
for MetALD from a limited spatial transcriptomic dataset. Building on these preliminary successes, our proposal
outlines two specific aims designed to further dissect the complexities of steatotic liver disease:
1. We will define the etiology and predict the severity of steatohepatitis using novel ML tools as follows:
a. Classify the etiology as ALD, MetALD, or MASLD on WSI based on ML.
b. Predict disease severity using a graph neural network model for comprehensive morphometric analysis.
2. We will identify distinct profiles that confer prognostic value for MetALD as follows:
a. Define zonal and unique regions of interest pathways of liver injury using spatial transcriptomics
b. Develop a multimodal prognostic algorithm for MetALD based on the histological features of the graph
neural network, clinical and serological findings, and spatial transcriptomics.
This proposal is technically and conceptually innovative, as it seeks to integrate histological features with
ML for diagnostic precision and disease severity prediction, advancing our understanding of the underlying
pathways of injury in MetALD. These outcomes will guide the development of noninvasive diagnostic and
prognostic markers, aligning with NIAAA’s mission to improve alcohol-related liver disease outcomes. This
proposal ensures that I achieve my goal of becoming an independent physician-scientist specializing in ML,
spatial transcriptomics, and liver diseases, through the advanced training and dedicated research time
provided by the K08 and the well-rounded mentorship and tremendous resources provided by the Mayo Clinic.

Public health relevance
PROJECT NARRATIVE Alcohol-associated liver disease (ALD), metabolic dysfunction-associated steatotic liver disease (MASLD), and metabolic syndrome-associated alcoholic liver disease (MetALD) are the leading causes of liver-related morbidity and mortality; however, they present significant challenges owing to overlapping histological features and the lack of accurate prognostic tools. This project aims to develop innovative diagnostic and prognostic tools using machine learning (ML) and spatial transcriptomics to accurately differentiate between these diseases and predict their severity, thereby improving precision medicine treatments. By integrating multi- omics data and advanced ML techniques, this research will enhance our understanding of MetALD pathogenesis and contribute to the development of noninvasive diagnostic and prognostic markers, ultimately advancing patient care for alcohol-associated liver diseases.